Using Microfluidics to Identify Mechanisms of Platelet Dysfunction and Assess Therapeutic Efficacy in Traumatic Hemorrhage

Using Microfluidics to Identify Mechanisms of Platelet Dysfunction and Assess Therapeutic Efficacy in
Traumatic Hemorrhage
Project Summary/Abstract
This proposal consists of a five-year plan to develop Susan M. Shea, PhD into an independent translational
scientist in the field of trauma-induced coagulopathy (TIC) and therapeutic assessment of hemostatic blood
products. Washington University School of Medicine (WUSM) is an outstanding institution for Dr. Shea to
establish her research program, as there is a longstanding history of NIH-funded research, as well as both
breadth and depth of resources available. Additionally, there is a high level of synergy and multidisciplinary
collaboration among departments, and with other institutions, both of which are manifested in Dr. Shea’s
proposed mentoring team and advisory panel. A structured educational program is proposed to provide Dr. Shea
with additional knowledge, technical skills, grantsmanship, networking, and mentorship required to achieve a
successful transition to independence.
Dr. Shea’s immediate goal is to fulfill the aims outlined in this proposal. Trauma is the most common cause of
death in the United States in individuals less than 46 years of age, to include 30,000 deaths from hemorrhage
per year that could be prevented with more timely and appropriate care. TIC occurs in 25% of trauma patients
and is associated with a 4 fold risk of mortality. Platelet dysfunction is one of the main etiologies of TIC, and is a
poorly understood phenomenon. TIC-related platelet dysfunction is challenging to study as current clinical
assays are not physiologically relevant to hemostatic function. Furthermore, the optimal therapeutic approach to
address TIC-related platelet dysfunction is unknown. The aims of Dr. Shea’s research in this proposal include
the following:
1. Characterize trauma-induced coagulopathy (TIC)-related platelet dysfunction in the context of
global hemostasis and its association with mortality.
2. Define the relative contributions of cellular and soluble mediators to TIC-related platelet
dysfunction.
3. Determine which transfusion strategies are effective at reversing platelet dysfunction in TIC.
The knowledge gained from the successful effectuation of these aims will result in novel insight into mechanisms
of trauma-induced platelet dysfunction and therapeutic efficacy. This will be the first time resuscitation of TIC will
be investigated in a microfluidic model of bleeding. Such a platform has the potential to be used for licensing of
hemostatic blood products, adjuncts, and agents, as well as to provide the biologic rationale for the development
of clinical trials that can assess the clinical efficacy of hemostatic products. This proposal is directly relevant to
National Heart, Lung, and Blood Institute (NHLBI) mission, as the long-term objective is to use a biofidelic model
of hemostasis to define the mechanisms of and develop therapies for TIC-related platelet dysfunction.

Public health relevance
Project Narrative Severe bleeding is the most common cause of preventable death after traumatic injury, and trauma-induced coagulopathy contributes to this condition and increases the risk of mortality by 400%. Platelet dysfunction is one of the major contributors to trauma-induced coagulopathy, and therefore a biofidelic microfluidic assay will be employed to study platelet contributions to clot formation and further clarify the impact and origins of trauma- induced platelet dysfunction, and will also be used to inform on the effect of platelet transfusion approaches to resuscitate severely bleeding trauma patient samples in vitro. This microfluidic platform can provide highly physiologically-relevant hemostatic function assessment in preclinical studies, and has the potential to cause a paradigm shift in the study of hemostatic resuscitation, thereby furthering understanding of trauma-induced coagulopathy and allowing optimization of the hemostatic function of blood products that are transfused into severely bleeding patients.